Impact of Microbial Dysbiosis on MAIT Cell Tissue Repair Program after Acute HIV Infection

Project Summary / Abstract
Mucosa-associated invariant T-cells (MAIT) are a subset of unconventional, innate-like T cells that are highly
abundant in mucosal tissues and peripheral blood and recognize microbial vitamin B2 (riboflavin) metabolites
from a wide range of microbes. Furthermore, MAIT cells have been recently shown to have tissue repair
functions. In HIV infection, MAIT cells are irreversibly lost in the blood and gut, and remaining cells display
elevated signs of activation with decreased functional potential. Another consequence of HIV is a profound
dysbiosis of the gut microbiome characterized by reshaped abundances of commensals turned pathogenic. HIV-
associated compromised gut mucosal immunity is thought to be a major driver of persistent immune activation,
viral replication, and morbidity and mortality, even in individuals who are on effective ART. Studies show that
chronic HIV infection is associated with reduced gut bacterial diversity and an enrichment in fusobacteria,
associated with reduced T cell counts and higher inflammation. Yet, the etiology of dysbiosis in HIV infection
remains unclear. We have an unprecedented opportunity to address this significant gap in knowledge by
leveraging matched biospecimens of gut tissue biopsies and peripheral blood mononuclear cells (PBMCs) from
treatment naïve and ART-treated acutely and chronically HIV infected individuals enrolled in an observational
HIV study in Thailand. Because of associations with gut integrity and control of microbial infections, the
dysfunction of MAIT cells in HIV-1 infection may leave the host with weakened mucosal and antimicrobial
immunity. To date, no studies have linked MAIT cells with surrogates of gut integrity, microbial translocation, or
specific makeup of the microbiota in gut tissue during HIV infection. The overall goals of the project are to: (a)
determine if imbalance in the normal gut microbiota impacts MAIT cell frequency, phenotype, and tissue repair
function across stages of HIV infection; and (b) to ascertain if ART initiated early in acute HIV infection alters the
relationship between the initial perturbations of the gut microbiota and the early engagement of the MAIT cell
compartment. In AIM 1, we will perform MAIT cell and microbiome analysis on matched PBMCs and plasma
samples from treatment naïve acutely HIV infected individuals, and HIV uninfected healthy controls matched for
age and gender. We will examine if increases in translocated fusobacteria are associated with change in MAIT
cells numbers and activation in the blood and gut. We will investigate if HIV-induced dysfunction of MAIT cells is
associated with markers of reduced gut barrier integrity. In AIM 2, we will use PBMCs and plasma samples from
uninfected and HIV-infected individuals that initiated treatment at different stages of acute infection to evaluate
the impact of ART initiation timing on microbial dysbiosis and MAIT cell tissue repair functions. In vitro
experiments will be performed to study the impact of fusobacteria on MAIT cell dysfunction. By investigating
these two aims we will determine if commensal and pathogenic gut microbiota tune the number, phenotype, and
functions of peripheral and gut MAIT cells in HIV infection.

Public health relevance
Project Narrative HIV infection alters the absolute numbers, phenotype, and function of a specialized subsets of T cells, mucosa- associated invariant T-cells (MAIT) cells, which are a cell type that play a major role in antimicrobial activity important for maintenance of homeostasis of the gut mucosal microbiome. Moreover, HIV infection alters the gut mucoscal microbiome during both acute and chronic infection with increases observed in the frequency of fusobacteria, which may be a consequence of a compromised gut immune system or potentially a cause of increased MAIT cell activation, altered phenotype, and functional impairment. This project aims to understand the interplay between host microbiota and MAIT cells in the earliest stage of acute HIV infection and chronic infection and may result in novel approaches to restoring MAIT cell function, homeostasis of the gut mucosal microbiome, and maintenance of gut integrity in people living with HIV.